Hippo-YAP in podocyte health and disease

Project Summary
A limited understanding of clinically relevant signaling pathways has limited the development of therapeutic
agents for human glomerular disease. Our long-term goal is to identify novel therapeutic targets for the treatment
of glomerular disease by elucidating the details and functional significance of key signaling pathways that
regulate podocyte injury and survival. Our preliminary data have shown that YAP silencing disrupts podocyte
focal adhesion architecture and actin cytoskeletal integrity. Using RNA-Seq to compare the transcriptomic profile
of control and YAP knockdown mouse podocytes, the most significantly enriched gene ontology molecular
function term among the differentially upregulated genes is “potassium channel regulator activity”. YAP silencing
significantly increases KCNN4 gene and encoded KCa3.1 (intermediate-conductance calcium-activated
potassium channel) protein expression. KCa3.1 inhibitors decrease podocyte actin cytoskeletal disruption,
pathogenic intracellular calcium signaling and potassium efflux along with decreasing podocyte injury in an acute
in vivo model of glomerular disease. The overall objective of this application is to define the role of YAP in
podocyte survival and as a potential therapeutic target in proteinuric kidney disease. Our hypothesis is that YAP
nuclear expression is essential for maintaining the integrity of the podocyte actin cytoskeleton, including through
repression of KCNN4 gene expression. The loss or inactivation of YAP enhances pathogenic KCa3.1 signaling
in podocytes. Our hypothesis will be tested by pursuing two specific aims: Aim 1 will define the mechanism of
Hippo-YAP regulation of podocyte KCa3.1 function. We will define the mechanism by which Hippo-YAP regulates
KCa3.1 channel function in podocytes and the mechanism of podocyte injury induced by calcium-activated
potassium channel activity. We will also test the in vivo interaction and functional role of YAP inhibition of
KCNN4/KCa3.1 function. In Aim 2, we will develop and test the efficacy of KCa3.1 inhibitors for podocyte
protection. We will use rational design and medicinal chemistry to optimize KCa3.1 inhibitors for podocyte
protection, test the ability of novel KCa3.1 inhibitors to protect podocytes from injury while decreasing pathogenic
potassium efflux and intracellular calcium signaling, and test the ability of KCa3.1 inhibitors to decrease
albuminuria and slow kidney disease progression in relevant in vivo glomerular disease models. Currently, there
are no KCa3.1 inhibitors in clinical development for podocytopathies, FSGS or proteinuric kidney disease. The
work proposed is expected to characterize the role of Hippo-YAP signaling in regulating KCa3.1 function in
podocytes while developing a novel therapeutic strategy for proteinuric kidney disease.

Public health relevance
Project Narrative Our preliminary data identified potassium dysregulation with YAP silencing and KCa3.1 (intermediate- conductance calcium-activated potassium channel) as a key regulator of podocyte survival and a potential therapeutic target in progressive glomerular disease. The proposed research will advance the currently available knowledge of glomerular disease pathogenesis and serve as a platform for developing a novel therapeutic strategy for proteinuric kidney disease.